The Impact of Prolactin Induced Protein in Corneal Wound Healing and Fibrosis

ABSTRACT
Corneal disease and injury are the third most common causes of blindness, affecting over 10 million people
worldwide. The majority of corneal blindness is permanent due to scarring; therefore, controlling the progression
and state of scarring is crucial for the maintenance of vision. Surgical techniques are improving; however, they
are very invasive and may have long-term complications. Clearly, there is a need for therapeutic intervention in
order to reduce the need for corneal transplantation, which is the most commonly used technique for treating
corneal scarring. In the current proposal, we propose to investigate a novel target for corneal scarring treatment
known as Prolactin-Induced Protein (PIP). PIP is a 17-kDa single polypeptide chain that is widely expressed in
cancerous breast tissue and is regarded as a diagnostic biomarker for the histopathological diagnosis of this
disease. We were the first to report the role of PIP in the context of cornea. Initially, we showed the interplay
between PIP and the transforming growth factor-β (TGF-β), and its ability to modulate all the TGF-β isoforms (in
vitro studies), and more recently we cemented PIP as a biomarker for keratoconus (clinical human studies).
During our recently published and preliminary studies, we observed PIP’s anti-fibrotic ability both in vitro and in
vivo, and discovered modulation of cellular metabolism and mitochondria health following exposure to PIP (in
vitro). Thus, we hypothesize that PIP is critical for corneal wound healing, following an injury/trauma, without the
presence of fibrosis. Utilizing minipigs in vivo and complementary in vitro and ex vivo models, we propose to
further explore these compelling findings and unravel the signaling mechanisms of PIP as well as determine the
efficacy of PIP eye drops, which seem to prevent corneal scaring in vivo. Successful completion of the proposed
studies could ultimately lead to the development of a new ocular drug for corneal trauma. We propose two
complementary, but independent, specific aims to examine the following questions: First, what is PIP’s signaling
cascade and mechanism-of-action? Second, can we develop PIP-based eye drops that can be used as an
alternative and non-invasive solution for corneal scarring treatment? Relevance to Public Health – Corneal
scarring is a major clinical problem and more often than not leads to complete or partial loss of vision. The
development of efficient, non-invasive corneal scarring drug, will likely help us move a step closer towards
resolving a sight threatening process.

Public health relevance
PROJECT NARRATIVE Corneal scarring is a major cause of blindness in the world today but its epidemiology is proven to be very complicated and dependent on a variety of factors, including trauma, infections, and inflammation. Currently, and for the last four decades, the only available treatment for corneal scarring is corneal transplantation; however, this therapy has significant side effects and concerns. Through our studies, we have shown that PIP can blunt fibrosis both in vitro and in vivo, and therefore, we propose to extend, modify, and optimize our findings in order to develop a novel therapeutic agent that can help ameliorate corneal scarring.